Health Systems Node of the NIDA Clinical Trials Network

ABSTRACT
Substance use (SU) and substance use disorders (SUD) cause extensive morbidity and mortality but have
been neglected historically by mainstream health care. The Health Systems Node joined the National Institute
on Drug Abuse’s Clinical Trials Network (CTN) in 2015, led by Drs. Campbell, Weisner and Bradley, addiction
research leaders in innovative implementation research and pragmatic trials in medical settings. Our node
includes 16 Learning Health Systems with national representation and rich population diversity, and represents
over 26 million patients. Our faculty are researchers who are embedded in their health systems and committed
to cutting-edge addiction research. They bring multidisciplinary expertise in conducting research using
innovative methods in different medical settings (e.g. primary care, addiction medicine, OB/GYN, psychiatry,
rural communities), and with diverse populations (e.g. under-represented minorities, adolescents, pregnant
women, patients with HIV). The node had an outstanding track record in its first 5 years leading 6 multi-site
studies, including the CTN’s first entirely electronic health record (EHR)-based pragmatic implementation trial
as well as participating in several studies led by other nodes. This renewal application builds upon that success
to address the CTN’s objectives over the next 5 years through 3 broad Research Agendas: 1) To test
approaches to increasing identification of SU and SUD, and engagement in treatment. For example, we
propose a multisite implementation trial to test an innovative approach to implementing cannabis and other
drug screening and assessment for SUD; 2) To test new approaches to improve SUD outcomes in medical
settings. For example, we propose a point-of-care pragmatic effectiveness trial of telephonic nurse
collaborative care and an efficacious smartphone-based SUD treatment, in patients with newly diagnosed
SUD; and 3) To develop novel measures and methods for SUD research using EHRs. For example, we
propose to validate a 7-item SU severity measure developed by the NIH Roadmap initiative Patient Reported
Outcome Measurement Information System (PROMIS) for use in measurement-based care of SUD. These
agendas emphasize population-based studies, including pragmatic randomized controlled trials, comparative
effectiveness studies, and implementation research, and leverage EHRs. Public Health and Clinical
Practice Impact. Over 14.9 million patients with untreated SUD have health care visits annually in the US. If
10% of these patients were identified, engaged and successfully treated, it would translate to 1.5 million
patients with resolved SUD each year who otherwise would have gone untreated. The Health Systems Node
faculty and infrastructure, in collaboration with the CTN, are uniquely positioned to conduct and disseminate
research that advances the integration of SUD treatment into routine medical care, and ultimately to improve
patient outcomes and public health.

Public health relevance
PUBLIC HEALTH RELEVANCE The vision of the Health Systems Node of the National Institute on Drug Abuse’s Clinical Trials Network is to transform treatment for substance use disorder through integration of care into real-word medical settings. Through its network of 16 learning health systems from across the United States, the Health Systems Node will conduct research that increases identification of patients who need care and identifies multiple effective treatment options. As part of the Clinical Trials Network, the Health Systems Node will continue to build the infrastructure required for high impact research to address the nation’s urgent need to address substance use disorder along the spectrum of care.